Synaptic Mechanisms of Stress-Induced Hypertension

Synaptic mechanisms of stress-induced hypertension Project Summary Hypertension is one of the most prevalent health problems and a well-recognized risk factor for many fatal diseases. Thus, it is crucial to identify the mechanisms responsible for the development of hypertension. Prolonged and repeated exposure to stress may cause chronic elevation of sympathetic nerve activity, which contributes to the development of hypertension. Individuals with a genetic predisposition to hypertension may develop a sustained elevation of arterial blood pressure even after removal of the stressor. However, little is known about the neural mechanisms underlying chronic- stress?induced persistent hypertension. Our long-term goal is to determine the synaptic mechanisms involved in stress-induced hypertension. This project will use borderline hypertensive rats (BHRs), the first-generation offspring of cross-breeding of spontaneously hypertensive rats and normotensive Wistar-Kyoto rats, to explore the molecular mechanism responsible for chronic stress-induced hypertension. The paraventricular nucleus (PVN) of the hypothalamus is a key brain site that mediates the stress response and is an important source of the excitatory drive that heightens sympathetic vasomotor tone in the development of hypertension. The preliminary studies showed that chronic stress increased the expression level of α2δ-1 in the PVN, which in turn interacts with the glutamate N-methyl- D-aspartate receptor (NMDAR) to increase its synaptic activity. The central hypothesis is that chronic stress transforms borderline hypertension into persistent hypertension through upregulation of α2δ-1 in the PVN, which interacts with NMDARs and leads to enhanced synaptic NMDAR trafficking and heightened sympathetic outflow. The hypothesis will be tested through pursuit of the following 3 specific aims: 1. Determine the extent to which chronic stress upregulates the expression levels of α2δ-1 and NMDARs in the PVN in BHRs. 2. Determine the role of α2δ-1 in the PVN in chronic stress-induced sustained hypertension in BHRs. 3. Determine whether α2δ-1 interacts with NMDARs and the role of α2δ-1 in enhanced NMDAR activity of PVN presympathetic neurons in BHRs with chronic stress- induced sustained hypertension. The proposed work is innovative because it will be the first study to investigate the interactions between α2δ-1 and NMDARs in the PVN in chronic stress?induced hypertension. The proposed work is highly significant because it will not only identify new molecular mechanisms underlying stress-induced hypertension but also may lead to the development of new treatments for neurogenic hypertension. 1

Public health relevance
PROJECT NARRATIVE Hypertension remains a prevalent clinical problem and a major risk factor for development of heart disease, stroke, and kidney failure. We plan to determine how the glutamate receptor activity is regulated in the hypothalamus in the development of stress-induced persistent hypertension. This proposal will identify a new target for treating neurogenic hypertension.